CORE---Animal Model

The purpose of this core is to provide a centralized facility in which all of the various animal procedures outlined in the Program Project may be performed. Personnel experienced in implementing murine models of cardiovascular disease in a rigorous and reproducible manner will staff the core. The main responsibilities of the core will be the performance and analysis of the following murine models: 1. Myocardial infarction 2. Peritonitis 3. Carotid arterial injury 4. Bone marrow transplant